Elucidating dietary fructose and alcohol interactions during liver cancer development

Project Summary/Abstract
Hepatocellular carcinoma (HCC) has been alarmingly increased, in part due to rapid increases
in fatty liver disease. Owing to the lack of early diagnostic markers, HCC's 5-year survival is only 10%.
Alcoholism is a well-known HCC risk factor, but the mechanism of how alcohol induces HCC is still
unclear. Another HCC risk factor is consumption of dietary fructose, especially in liquid form (soft
drinks), which has increased 100-fold over the past two centuries. Based on our preliminary data, we
hypothesize that fructose alters hepatic alcohol metabolism via induction of acetyl-CoA synthetase 2
(ACSS2), which enhances the hepatic usage of alcohol carbons to generate carcinogenic metabolites
and thereby creates a pro-tumorigenic environment. When alcohol reaches the liver, it is converted to
acetate and mostly released into circulation. However, when ACSS2 is activated, flux is shifted from
acetate release to acetate catabolism, resulting in excessive production of acetyl-CoA, a high-energy-
charged, reactive metabolite. This alteration can initiate and support HCC in many ways, including
carcinogenic metabolite production. Indeed, ACSS overexpression and increased acetate usage are
commonly observed in cancers including HCC. We recently found that mice exposed to fructose
showed strongly induced hepatic ACSS2 activity and acetate usage. Thus, fructose drinking will shift
the metabolic fate of alcohol from release as acetate to usage of acetate within the liver. Fructose
drinking also induces gut leakiness and alters microbiota metabolism. The resulting toxic microbiota
metabolites cause chronic hepatic inflammation, which is a pro-tumorigenic microenvironment. We will
test these hypotheses by systematically defining the impact of fructose-elicited ACSS2 induction and
microbiota changes on liver alcohol metabolic flux. In Aim 1, we will determine whether and how
fructose and alcohol synergistically increase HCC risk. Using in vivo stable isotope tracing of 13C-
ethanol and hepatic-portal comparative metabolomics in mice, we will quantitatively define progressive
changes of hepatic alcohol metabolism during HCC initiation and progression. This will build a
comprehensive catalog of HCC-associated, alcohol-derived metabolites. We will then choose the top
candidate metabolites and test whether these metabolites can trigger HCC. In Aim 2, we will test our
hypothesis that fructose-induced hepatic ACSS2 activity and/or colonic microbiota changes enhance
carcinogenic metabolite production in the liver, thereby triggering HCC. To this end, we will use our
newly generated liver-specific ACSS2 knockdown mice and antibiotics treatment. These studies will
provide molecular evidence for a clinically relevant question about how the two best-known dietary risk
factors, alcohol and fructose, synergistically initiate and advance HCC. Our study's success will have
direct impacts on public dietary guidelines and provide mechanistic insights into alcohol-induced HCC.

Public health relevance
Project Narrative Excessive consumption of fructose or alcohol causes fatty liver and occasionally liver cancer, but whether these two dietary risk factors synergistically induce liver cancer is unknown. In this proposal, we will determine how fructose intake alters liver handling of alcohol to increase liver cancer risk. To achieve this goal, we will employ state-of-the-art mass spectrometry and our newly generated genetically modified mice.